Modeling functional genomics of susceptibility to the persistent effects of environmental toxins in an elderly rural Indiana neurodegenerative cohort

PROJECT SUMMARY
Alzheimer's disease and related dementias (ADRD) have become a growing public health crisis and are one of
the major causes of disability among people over 65. Even though it was discovered over a century ago, its
driving mechanism remains poorly understood, which limiting intervention options. Scientists believe that ADRD
is caused by many genes through complex interactions with environmental factors. Over 70 genetic regions have
been identified to be associated with ADRD; however, how these genes contribute to disease penetrance and
progression remains elusive. Therefore, a comprehensive characterization of gene regulations at single-cell
resolution is warranted to understand the molecular mechanism and discover therapeutic targets for ADRD.
Recent advances in single-cell sequencing technologies, especially the simultaneous measurement of gene
expression and chromatin accessibility for the same cell, along with the community efforts to share omics data
provide unprecedented opportunities to unravel the dynamic molecular mechanism of ADRD. To understand the
contribution of gene-environment (GxE) interactions and leverage single-cell genomics approaches and pathway
analysis, we propose to test the hypothesis that persistent neurotoxicity is due to exposures altering self-
perpetuating homeostatic processes that give the resiliency and perpetuity to the adverse toxicological processes
by either genetic and/or epigenetic means in the parent R01. More specifically, we propose to identify genetic
pathways associated with establishing a persistent neurotoxic state via single-cell genomics and bioinformatic
comparisons to population level data in Aim 2; and Aim 3 focuses on the validation of the genetic pathways of
GxE induction of persistent neurotoxicity with in vivo and in vitro models.
To augment the parent R01 and integrate single-cell human brain tissue data from healthy individuals available
through The BRAIN Initiative, the overarching goal of the supplement is to identify the network alterations of AD
patients by comparing them to those from healthy human brain tissues. This supplement is built upon our
proposed new machine learning tools for network construction by integrating snRNA-seq and snATAC-seq data
in the parent R01 and our recent successful demonstration of constructing a genome-wide gene regulatory
network using bulk RNA-seq and SNP data based on a two-stage penalized least square method. Specifically,
we will (1) Harmonize the single-cell RNA and ATAC data from the “NeMO” and “SEA-AD” studies, and (2)
Conduct transcriptome-wide causal inference on gene regulation for healthy and AD/ADRD cohorts. Results
from the single cell analysis of parent R01 and this supplement provides a comprehensive evaluation of genetic
and environmental factors and their complex interactions during the initiation and progression of ADRD, which
ultimately provide new insights into the altered gene regulation of ADRD that could provide a foundation for
developing new strategies to prevent, delay, or treat ADRD. Our integrative machine learning tools will be shared
through open-source programs, which can benefit single-cell-based research in the broader scientific community.

Public health relevance
PROJECT NARRATIVE The overarching goal of the proposed project is to understand the molecular mechanism of Alzheimer's disease and related dementias (ADRD) by leveraging the publicly available single-cell data from human brain tissues. We will apply the novel machine learning methods for gene regulatory network construction proposed in our parent R01 to single-cell data from healthy individuals and patients with ADRD. Results from these analyses will augment the power of the statistical analysis in our funded R01 study; and collectively facilitate the development of new strategies to prevent, delay, and treat ADRD.